Exploring the role of metagenomic deep sequencing for trachoma

PROJECT SUMMARY
Trachoma, still the world’s leading infectious cause of blindness, has been slated for elimination by 2030 by the
World Health Organization (WHO). The elimination strategy, which relies to a large extent on annual mass
azithromycin distributions, has been tremendously effective. But in some parts of the world with hyperendemic
trachoma, elimination has not occurred despite more than a decade of annual mass azithromycin distributions.
It is unclear why trachoma has remained stubbornly high in these places. It is possible that mass antibiotic
treatments are simply not reaching enough people, but other theories have also been introduced, including the
possibility of (i) antimicrobial resistance in the causative organism, Chlamydia trachomatis; (ii) extraocular
reservoirs of chlamydia transmission such as the rectum; and (iii) non-chlamydial organisms that may cause a
follicular conjunctivitis resembling trachoma. These theories have largely gone untested.
This grant proposal seeks to leverage swabs already collected as part of other NIH-funded studies, performing
metagenomic deep sequencing (MDS) to explore theories for persistent trachoma. MDS can identify all DNA
and RNA sequences of a specimen in an unbiased way, and is thus useful for pathogen discovery and for
assessment of gene expression. We will use MDS to assess the temporal stability of DNA and RNA sequences
of chlamydia over a 4-week period, providing benchmarks on the amount of variability that could be expected.
Such information will be extremely helpful when planning and interpreting future studies. We will also compare
MDS results from children who did and did not clear their chlamydia infection after azithromycin treatment,
providing clues about possible antimicrobial resistance genes. We will use MDS in children with chlamydia
recovered from both their conjunctival and rectum in order to determine if each site has the same strain of
chlamydia. Finally, we will use MDS in a group of children without chlamydia infection but with the clinical signs
of trachoma to see if some unknown pathogen is responsible for causing clinical features consistent with
trachoma.
These exploratory analyses will be useful for providing benchmarks for future studies of MDS for ocular
chlamydia, while at the same time furthering our knowledge about the potential role of antimicrobial resistance,
extraocular chlamydial reservoirs, and non-chlamydial infections for trachoma.

Public health relevance
PROJECT NARRATIVE We propose performing metagenomic deep sequencing on conjunctival and rectal swabs that have been collected as part of several previous NIH-funded trachoma studies. The proposed analyses will provide benchmarks for future studies of metagenomic deep sequencing for trachoma, and also provide information on the potential role of antimicrobial resistance, extraocular reservoirs of chlamydia, and non-chlamydial pathogens for persistent trachoma.